SYNAPTIC PLASTICITY DURING AGING AND ALZHEIMERS DISEASE

One of the most intriguing features of brain aging is the tremendous variability in the loss of cognitive function and plasticity. Certain individuals function alertly up to 90 years of age whereas others show decline of intellectual ability as their mid-50's and in the extreme form, develop clinical dementia such as Alzheimer's disease. What are the factors that might account for the loss of plasticity and cognitive functions in the aging brain and, what role(s) do they play in the impressive individual variation observed during aging in human and rodent: We are examining molecular mechanisms involved in the CNS reinnervation process that might regulate the abnormal compensatory plasticity reported in brain aging and in Alzheimer's disease. We recently showed that the brain has evolved a powerful mechanism allowing lipid recycling from degenerating neurons to reinnervating ones. This process relies on the synthesis of apolipoprotein E by astrocytes (for lipid transport) and, the up-regulation of its receptor (LDL receptor) by neurons. Preliminary data indicates that this recycling pathway is compromised in patients with Alzheimer's disease and, in lesioned rat exposed to glucocorticoid levels similar to those measured in aged rats. Studies proposed here will examined a) the role played by the LDL receptor during normal reinnervation process in young rats and, b) how it regulates cholesterol synthesis and storage in brain cells. We will also attempt to relate changes in hypothalamic-pituitary-adrenal (HPA) function (glucocorticoid status) to individual differences in hippocampal synaptic plasticity in later life using animal models of both "successful aging" (low corticosterone level and absence of cognitive decline) and "unsuccessful aging" (high cort level and presence of cognitive decline). We anticipate to demonstrate a relationship between the loss of cognitive function in aged rats and a glucocorticoids-mediated, cholesterol-recycling-dependent reduction of hippocampal synaptic plasticity. We hope to show that changes in HPA function can be used to predict individual differences in cholesterol recycling and hippocampal plasticity in aged rats. Finally, we will examine whether the loss of apolipoprotein E expression observed in the hippocampus of AD relates to the reported absence of synaptic plasticity in these patients. We will also examine the possibility that cholesterol synthesis and re-uptake could be up-regulated by local hippocampal neurons to compensate for the loss of apolipoprotein E expression. These experiments will allow us to go beyond the variable of chronological age, and examine some of the factors possibly responsible for a decreased synaptic plasticity associated with aging and Alzheimer's disease.